Decoding the Cell-specific Impact of Epigenomic and Alternative Splicing Regulation during T1D Progression

Abstract.
Type 1 diabetes (T1D) is characterized by the destruction of pancreatic β cells, which respond to signals from
immune cells, leading to hyperglycemia. This study aims to grasp the mechanisms influencing T1D by
investigating both intrinsic β cell factors and environmental immune cell interactions. Our interdisciplinary team
combines expertise in diabetes genomics, stem cell/organoid biology, and islet biology to explore these
dynamics. The preliminary studies using single-cell transcriptome, single nucleus chromatin accessibility, and
single nucleus (sn) multiome profiling of human pancreatic islets from healthy and T1Daffected individuals. The
same experiments were performed using human islets exposed to cytokines or virus simulating T1D conditions.
Our integrative approaches identified gene regulatory elements (GREs) at diabetes GWAS. Also, we have
developed tactics to differentiate human pluripotent stem cells (hPSCs) into functional vascularized-immune islet
organoids containing pancreatic endocrine cells, endothelial cells and immune-like cells. Here, we will apply sn-
multiomic (both short and long reads RNA-seq and ATAC-seq) profiling, hPSC-derived organoids, CRISPR-
based gene editing and Cas13-based gene knockdown to systematically explore the role of intrinsic and
environmental signal dynamics in T1D progression and define mechanistic network controlling β cell destruction.
We propose three specific aims to advance our understanding: Aim 1: Define the cell-specific multiomic intrinsic
and environmental signatures during T1D progression. We will characterize intrinsic and environmental changes
in chromatin and transcriptome profiles of islets from pre-T1D, T1D, and healthy individuals, map gene/isoform
expression and chromatin accessibility, and finally integrate multi-omics data to identify cellspecific quantitative
trait loci (QTLs) and perform fine mapping with T1D GWAS signals. Aim 2: Decode the epigenomic network
controlling β cell destruction during T1D progression. We will use massively parallel reporter assays to validate
GREs at T1D GWAS loci, employ Perturb-seq and CRISPR editing to validate GREs, target genes, and their
cellular phenotypes in isogenic hPSC-derived organoids. Aim 3: Determine the impact of alternative splicing on
human β cell destruction. We will validate T1D-associated alternative splicing using the Xenium platform. Finally,
we will examine the biological function of gene isoforms, and reverse β cell destruction in hPSC-derived
organoids by targeting alternative splicing mechanisms.
Our long-term goals include identifying locus-specific and network mechanisms to facilitate the development for
precision medicine approaches in T1D. Key deliverables will include a comprehensive single cell triple-omic map
of human islets crossing different stages of T1D progression, a molecular genetic network of intrinsic and
environmental signals, and validated hPSC-derived vascularized immune-islet organoid models with
T1Dassociated GRE KO, gene isoform KD, etc. These findings will pave the way for the development of novel
therapeutic strategies and disease progression markers for T1D.

Public health relevance
Project Narrative. The progression of type 1 diabetes (T1D) is influenced by both intrinsic and environmental signals. Our proposal involves utilizing single nucleus transcriptome and chromatin profiling, along with human pluripotent stem cell models, to thoroughly investigate how these factors affect the function, and survival of human pancreatic β cells in both healthy and diseased states. Gaining a deeper understanding of the roles played by intrinsic and environmental signals will greatly improve our knowledge of β cell destruction during T1D progression, which will ultimately pave the way for developing precision therapy for T1D patients.